Cognitive Motor Interference Assessment for Improving Neurologic and Physical Disability Outcomes in Survivors of Severe Acute Respiratory Failure (CAMINANDO) Phase II

Project Summary/Abstract
Severe acute respiratory failure is the most common organ failure in the intensive care unit, the most severe
form of which is acute respiratory failure syndrome. Understanding and preventing the long-term physical and
cognitive impairments that is the legacy of surviving acute respiratory failure (ARF) is the career goal of this
junior minority investigator with previous clinical training in Pulmonary, Critical Care and research training in
Clinical Epidemiology. Although previous research in ARF has examined mobility outcomes independently
from the cognitive outcomes, emerging evidence suggests that mobility and cognitive outcomes are
intertwined. Cognitive Motor Interference (CMI) is an emerging risk assessment and treatment approach for
improving disability outcomes in many patient populations. Dr. Hope describes a mentored research project
and specific career development plan which will enable him to become an expert in CMI assessments in
patients with acute respiratory failure. The research proposal aims to leverage the NHLBI funded Prevention
and Early Treatment of Acute Lung Injury (PETAL) network to define the scope, pattern and predictive validity
of assessing acute respiratory failure patients for CMI while in the hospital. The research proposal's second
aim is to conduct a single-center randomized clinical trial of hospital based CMI-based training in acute
respiratory failure patients. During the award period, Dr. Hope has developed a structured plan to build on his
previous training by attaining skills in four additional areas: 1) measuring cognitive motor interference in acutely
ill patients; 2) understanding and intervening on disability outcomes after critical illness; 3) the management of
clinical trials and 4) structured equation modeling. As part of this career development award, Dr. Hope will be a
co-Principal Investigator for PETAL network studies at his institution and will serve as site Principal Investigator
for an NHLBI funded ancillary study called PRIMROSE. As a member of the PETAL Network Long-Term
Outcomes Working Group Committee, he will be involved, along with his mentors and collaborators, with
developing recommendations for measuring long-term outcomes in the PETAL network studies. Dr. Hope will
work closely with co-mentors in Neurology, Geriatrics and Critical Care with expertise in cognitive and mobility
outcomes; He will also work with advisors and collaborators in Rehabilitation Medicine with expertise in the
disability process in acutely ill patients. Through a mix of formal and informal coursework, practical experience,
local and international meetings along with directed feedback from this multi-disciplinary team of mentors and
advisors, Dr. Hope will be prepared to become an independent investigator by the end of this award period.

Public health relevance
Project Narrative Severe acute respiratory failure in the hospital is a common and morbid condition with high short-term mortality and a legacy of long-term mobility and cognitive impairments after hospital discharge. This project aims to use knowledge about the interconnection between mobility and cognition to test new approaches to treat and prevent adverse outcomes in patients with acute respiratory failure.